Establishing the mechanism of benefit and dose of exercise required to improve liver histology in patients with nonalcoholic steatohepatitis

Establishing the mechanism of benefit and dose of exercise required to improve liver histology in
patients with nonalcoholic steatohepatitis
PROJECT SUMMARY— In this career development program, I will study how exercise improves nonalcoholic
steatohepatitis (NASH) and answer three highly significant questions about exercise’s (1) mechanism of benefit,
(2) dose, and (3) impact on liver histology. This program builds on my clinical experience in NASH through
mentored training in: (1) mechanistic study (Dr. Scot Kimball), (2) exercise (Drs. Kathryn Schmitz, Christopher
Sciamanna), and (3) NASH trials (Dr. Rohit Loomba). The central hypothesis of this proposal is that exercise
training will activate AMP-activated protein kinase (AMPK) by depleting liver glycogen, leading to liver
fat reduction and intermediate histologic endpoint improvement in patients with NASH. Because
glycogen is the main substrate used during exercise to generate ATP, I hypothesize exercise will lead to glycogen
dissociation from AMPK and subsequent AMPK activation. The central hypothesis is based on a 16-wk proof of
concept study in 18 adult patients with NASH in which I found only those who completed a 750 Metabolic
Equivalents of Task (MET)-min/wk dose of exercise achieved the minimal clinically important difference in
magnetic resonance imaging proton density fat fraction (MRI-PDFF) measured liver fat, that surrogates for
histologic response. I observed this in parallel with indirect changes in the AMPK pathway, suggesting AMPK
was activated by exercise. While I did not study exercise dose >750 MET-min/wk, it is plausible that higher doses
may be even more effective because glycogen depletion requires sustained moderate-vigorous intensity
exercise. Given these pilot data, I will conduct a 16-wk clinical trial and randomize adults with NASH to different
exercise doses (750 or 1,000 MET-min/wk) or standard clinical care. To ensure adherence, each exercise
session will be completed under direct supervision, either in-person or remotely with telehealth, followed by
immediate calculation of exercise dose as intensity (METs) x frequency (one session) x time (min). In Aim 1, I
will study the mechanism of exercise’s benefit with MR-spectroscopy measured change in liver glycogen and
ATP following a single session of sustained moderate-vigorous exercise. In Aim 2, I will discern which dose is
most effective in reducing MRI-PDFF after 16-wks of exercise training. In Aim 3, I will measure important
intermediate histologic endpoints (NASH activity score) and mechanisms (AMPK activation, AMPK targets). Co-
localization of glycogen binding to AMPK in liver tissue will be used to confirm indirect MR-spectroscopy evidence
from Aim 1. When I am successful, I will have provided rigorous evidence to decipher the dose required and the
underlying mechanisms explaining how exercise training leads to improvement in intermediate histologic
endpoints, including NASH activity. This research will inform future trial design by generating data for sample
size estimates necessary to study exercise’s impact on long-term histologic outcomes, including liver fibrosis. I
am committed to a career as a physician scientist and have constructed my training plan to achieve scientific
independence and make substantial contributions to advancing the study of NASH and public health.

Public health relevance
PROJECT NARRATIVE—There is no cure or effective drug therapy for nonalcoholic fatty liver disease (NAFLD), the leading cause of chronic liver disease worldwide. Consequently, exercise is an important part of NAFLD treatment, however, questions remain about how clinicians should prescribe exercise and why exercise is effective. To better understand this, patients with NAFLD will participate in an exercise program that will study how different exercise doses target abnormal metabolic pathways and lead to improvement in NAFLD activity.